Cataractogenesis, Connexin Mutants and Genetic Modifier(s)

Project Summary
Genetic variances, environmental stress factors and aging can initiate pathological conditions in lens cells
leading to different types of cataracts. Previous studies show that the postnatal onset and severity of lens
nuclear cataracts are impacted by a functional loss of connexin 46 (Cx46) with genetic variances including
CP49 and periaxin (Prx) occurred between mouse strains C57BL/6J (B6) and 129 Svjae (129). This research
proposal will evaluate novel hypotheses about how intercellular gap junctions consisting of Cx46 and Prx
mediated membrane/cytoskeletal complexes coordinately regulate interior lens fiber cell morphogenesis and
calcium homeostasis needed for lens transparency. This project will provide a comprehensive mechanistic
understanding about how calcium influx and efflux as well as interlocking structures of lens fibers are
regulated and maintained by the adhesion and transport mosaic systems including gap junctions, Aqp0, calcium
channels linked to cytoskeletons through scaffold proteins such as Prx. Completion of this research project will
also provide essential knowledge about genetic variations among common mouse strains such as C57BL/6J
and 129 to the lens research community.

Public health relevance
Project Narrative Cataracts remain as the leading cause of blindness in the world. Lens transparency relies on a bulk of elongated and interlocked fiber cells, coupled into a syncytial unit by gap junctions. This project will elucidate the gap knowledge about the mechanistic regulation of fiber cell interlocking structures including protrusions and ball-and-sockets and lens calcium homeostasis. This project will further identify novel genetic variances that are essential for the formation and maintenance of lens transparency throughout lifetime.